Leveraging the plasma virome as a biological indicator of HIV risk and transmission networks among people who inject drugs

PROJECT SUMMARY
Meeting targets set to end AIDS as a major public health threat by 2030 requires reaching all populations,
particularly those with the highest burden, such as people who inject drugs (PWID). PWID continue to
experience some of the fast-growing HIV epidemics globally. Injection drug use is increasingly accounting for
new HIV infections in both low- and middle-income countries and countries that once saw notable declines in
HIV incidence among PWID. Even in countries with notable declines in HIV incidence among PWID, such as
the United States, the rise of prescription opioid use has resulted in increased heroin injection, increased
overdose rates, and outbreaks of HIV. Despite decades of investigation into the behavioral drivers of HIV
incidence, accurately predicting who is at the highest risk of becoming infected with HIV remains challenging.
Yet, this information is critical for preventing outbreaks and tailoring interventions. These tools are even more
critical at the final stages of disease control, elimination, or eradication programs which require
disproportionately more effort and resources than in preceding stages to identify those at risk, especially in a
setting of dwindling resources and emerging pandemics. As we rapidly approach the ambitious 2030 targets,
the same will be true of HIV, even more so among hard-to-reach populations such as PWID, and we need
early warning systems to guide a more targeted public health response
We previously demonstrated that PWID accumulate blood-borne nonpathogenic viruses in the plasma before
hepatitis C virus infection. We also have early data showing that sequences of these nonpathogenic viruses
reveal epidemiologic links. This study builds on these findings to explore whether the plasma virome in PWID
can be further used as a bioindicator of HIV risk and whether it can be leveraged to interrupt HIV outbreaks
before they occur. To test this, we utilize a rare set of longitudinal social (injection partner) and spatial (injection
venue) network data along with detailed individual-level risk factors and HIV sequences from a high-incidence
cohort of over 2,500 PWID in New Delhi, India. To date, this cohort has observed over 159 HIV
seroconversions. We plan to characterize the plasma virome using baseline specimens from participants who
later acquired HIV to determine if virome richness independently predicts HIV incidence and to assess the
added value of a bioindicator over established risk prediction tools. Additionally, we plan to sequence
participants comprising complete contact networks and leverage next-generation sequencing approaches that
capture the diversity of nonpathogenic viruses circulating within and between hosts to employ phylogenetic
methods aimed at determining whether plasma virome sequences can accurately infer transmission networks.
By using routinely collected samples, this work could lead to more robust molecular surveillance methods that
can guide public health officials in targeting interventions to prevent HIV outbreaks and focus limited resources
for the greatest impact.

Public health relevance
PROJECT NARRATIVE Despite decades of investigation into behavioral drivers, understanding the gradient of HIV risk among people who inject drugs (PWID) and designing effective tools to predict this risk remains a challenge. This study will evaluate novel use of the plasma virome as a sentinel bioindicator of HIV risk, as well as elucidate whether the virome can reveal potential transmission networks before HIV infection occurs. This represents a particularly innovative approach to HIV treatment and prevention and may lead to more robust molecular surveillance methods that can guide public health officials in targeting interventions to prevent HIV outbreaks and focus limited resources for the greatest impact.